1/2 Cell Type and Region-Specific Regulatory Networks in Human Brain Development and Disorders

ABSTRACT
Recent advances in genetics and genomics have identified hundreds of coding variants that increase risk for
major neuropsychiatric disorders, such autism spectrum disorder. Work to clarify the contribution of non-coding
variants is also underway and is expected to accelerate rapidly in the next few years. While these advances
have considerably improved our understanding of the genetic landscape neuropsychiatric disorders, a deeper
understanding of molecular pathophysiology is still missing. This knowledge gap is due to, in part, the
heterogeneity of risk loci involved, their potential roles in regulating expression of a large number of genes, the
pleiotropic nature of risk genes, and the high likelihood that neuropsychiatric disorders result from dysfunctional
circuitry involving multiple cell types and brain regions, altogether making the identification of molecular and
cellular mechanisms underlying a disease problematic, especially in the context of the protractive and complex
nature of brain development. Therefore, the discovery and characterization of the full spectrum of functional
genomic elements active in the human brain, as well as their activity/expression patterns across the
spatiotemporal dimensions, is essential for clarifying when, where, and what cell types are relevant to the
etiology and treatment of neuropsychiatric disorders. This is particularly so in the context of non-coding
variants, which are difficult to annotate, yet potentially hold the promise of providing highly specific spatial,
temporal, and cell type specific information. To address this knowledge gap and to continue our contributions
to the PsychENCODE Consortium, we propose four specific aims that identify gene regulatory and cell type-
specific mechanisms of human neurodevelopment. In Aim 1, we identify functional genomic elements across
single cells (nuclei), cell types, regions and developmental time points of neurotypical human and macaque
postmortem brains. In Aim 2, we map the spatio-temporal proteome of neurotypical human and macaque
postmortem brains. In Aim 3, we perform integrative identification of functional genomic elements and
proteomics in diseased brains and iPSC-derived neural cells. In Aim 4, we integrate results from Aims 1-3, as
well as with independent genetic datasets of neuropsychiatric populations, to identify non-coding elements,
genes, or molecular pathways that will lead to a better understanding of the underlying pathophysiological
mechanisms of neuropsychiatric disorders. Finally, these mechanisms will be functionally characterized in
model systems. Data from this proposal will also serve as a critical new resource for members of the
community, with which they can intersect their results and draw deeper and more meaningful conclusions,
especially as the wealth of genomic data from neuropsychiatric disorders continues to accumulate.

Public health relevance
NARRATIVE The discovery and characterization of the full spectrum of human functional genomic elements across brain regions, cell types, and developmental time periods is essential for clarifying when, where, and what cell types as well as which molecular pathways are relevant to the etiology and treatment of neuropsychiatric disorders.